Neurophysiological mechanisms of anhedonia and cognitive control deficits in trauma-exposed people completing vibroacoustically augmented breath focused mindfulness

PROJECT SUMMARY/ABSTRACT
Trauma can contribute to the development of dampened reward processing (anhedonia) and disrupted cognitive
control, which are precipitants and perpetuators of symptoms in mental health disorders. The neurophysiological
underpinnings of trauma-related anhedonia and cognitive control deficits has previously been examined using
cross-sectional approaches, including electroencephalography (EEG) studies demonstrating that activity in theta
(~4-7 Hz) and alpha (~8-14 Hz) frequency bands are aberrant in patients with anhedonia and cognitive control
deficits. To build upon this prior work and increase the translational value of these findings, one next step is to
examine how these cortical dynamics vary within a sample of trauma-exposed people to examine how individual
differences in symptom presentation relate to neurophysiology. Further, testing how these dynamics change
throughout a mindfulness-based intervention could reveal novel mechanisms of response to this intervention.
Thus, changes in theta/alpha activity could relate to response to a novel transdiagnostic treatment for trauma-
exposed people called vibroacoustically-augmented breath focused mindfulness (VABFM). VABFM uses a
unique device that vibrates in concert with respiration, which is expected to enhance stimulus sensitivity and
efficiently engage attentional control networks, but no studies to date have examined relevant neurophysiological
mechanisms. The proposed study will leverage data from an ongoing mechanistic clinical trial of mindfulness-
based treatment for trauma-exposed people (R01AT011267) who complete VABFM or a control intervention.
100 participants from this study will complete EEG recordings concurrent with eight bi-weekly intervention
sessions, and participants will also complete pre- and post-study structural and functional magnetic resonance
imaging (sMRI/fMRI) scans. Each sMRI scan will be used for co-registration for EEG source localization analyses
of theta/alpha activity. Source-localized cortical maps will be used to accomplish the following specific aims: (1)
characterize neurophysiological correlates of anhedonia and cognitive control deficits in trauma-exposed people
and (2) Identify neurophysiological mechanisms of VABFM treatment response relevant to anhedonia and
cognitive control in trauma-exposed people. Additionally, an exploratory aim will test congruence between
fMRI/EEG measures of anhedonia and cognitive control deficits in trauma-exposed people by using fMRI data
collected during performance of an affective cognitive control task, which includes reward-related stimuli. This
research will improve our understanding of the neurophysiology of anhedonia and cognitive control deficits in
trauma-exposed people with mental health disorders, and it will demonstrate how changes in symptoms relate
to changes in the underlying neurophysiology of reward/attention networks. Overall, these data provide a unique
opportunity for comprehensive neurophysiological phenotyping of anhedonia and cognitive control deficits in
trauma-exposed people and to identify neurophysiological mechanisms of a novel attentional control treatment.
This will delineate individual differences in brain mechanisms of mental health disorders and will guide treatment.

Public health relevance
PROJECT NARRATIVE Trauma can contribute to the development of dampened reward processing (anhedonia) and disrupted cognitive control, which are precipitants and perpetuators of symptoms in mental health disorders. This mentored-training project will use electroencephalography to characterize neurophysiological correlates of anhedonia and cognitive control impairment in trauma-exposed people, and it will identify the neurophysiological mechanisms of response to treatment in those completing a novel mindfulness-based intervention called vibroacoustically-augmented breath focused mindfulness. Results from this study will delineate individual differences in brain mechanisms of mental health disorders and inform future intervention strategies for trauma-exposed people with these disorders.